Neural Mechanisms of Performance Evaluation During Motor Sequence Learning

PROJECT SUMMARY
Double faulting on match point is intensely disappointing. Yet it is also a performance error that could help
improve your future serve. ‘Limbic’ structures such as the lateral habenula (LHb), ventral pallidum (VP) and
ventral tegmental area (VTA) have classically been associated with hedonic functions. But this emphasis might
result from behaviorist traditions that train lab animals with rewards and punishments. A more general function
of the limbic system may be to impose valence on any prediction error, including mistakes that occur during
motor performance. If this is the case, then decades of progress on how the brain processes reward can
generalize to motor sequence tasks such as speech, sport, and musical performance. In past work, we
discovered that when a male songbird unexpectedly sings the right note, its VTA dopamine (DA) neurons are
activated in the same way as when a thirsty primate unexpectedly receives juice. And following song errors, its
DA neurons are suppressed as when a primate experiences disappointing reward omission. We also found that
when males sing to females, these performance evaluation signals are turned off and DA neurons are instead
activated by female calls. These discoveries have important implications for motor learning circuits that motivate
the proposed work. Frist, to determine how performance quality is evaluated in circuits upstream of VTA, we will
anatomically identify inputs to VTA, perform lesions to test which are necessary for song learning, record VTA
responses to microstimulation of distinct inputs, and conduct neural recordings to identify auditory error and/or
timing signals important for error computation (Aim 1). Second, in past work we identified the VP as a hub for
auditory, motor, and error processing during singing. In pilot experiments we are identifying LHb and subthalamic
nucleus (STN) as novel targets of VP that also project to VTA. To dissect VP’s role in performance evaluation,
we will anatomically define VP inputs and outputs, and will record STN-, LHb-, and motor cortex-projecting VP
neurons during singing (Aim 2). Finally, our past discovery that DA error signals are turned off when males sing
to females is unprecedented. To determine if DA signal gating is behaviorally relevant, we first test if males can
learn from experimentally controlled errors with females present (Aim 3.1). To test if error signals are gated off
globally, we will record neurons in VTA-projecting areas (auditory cortex, VP, STN, LHb) as we control both
perceived error and female presence (Aim 3.2). Altogether, these studies will identify the neural correlates of the
internal evaluation systems that construct motor sequences. A major impediment to understanding pathological
activity patterns observed in BG-related diseases is a limited understanding of signal propagation through the
healthy circuit. The proposed work aims to understand the functions of DA-BG signals and how they are
processed at successive stages of the circuit. At stake in this issue is the potential to tailor therapies, such as
neural circuit re-programming and deep brain stimulation for movement disorders, based on detailed knowledge
of normal brain physiology.

Public health relevance
PROJECT NARRATIVE The basal ganglia are a set of brain nuclei highly conserved among vertebrates, including humans, critical for motor control and trial-and-error learning. This proposal will leverage advantages of a highly tractable model system, the songbird, to determine how the basal ganglia control and evaluate motor performance, two processes that go awry in a wide variety of basal ganglia diseases.